FAAH-regulated endocannabinoid signaling controls nociception in acute pancreatitis

PROJECT SUMMARY/ABSTRACT
Acute pancreatitis (AP) is a prevalent gastrointestinal disorder characterized by severe abdominal pain,
leading to substantial hospital admissions worldwide. The current reliance on opioid analgesics for pain
management in AP introduces risks such as abuse, dependence, and possibly exacerbated disease
outcomes. Emerging evidence suggests that the endogenous lipid-signaling molecules anandamide and
palmitoylethanolamide (PEA), which produce analgesia through non-opioid mechanisms, could offer a
promising alternative for pain relief. However, their therapeutic potential is limited by rapid breakdown via the
enzyme fatty acid amide hydrolase (FAAH). This project seeks to explore FAAH-regulated lipid signaling as
a novel, opiate-sparing therapeutic target for managing AP pain. Preliminary studies have demonstrated that
inhibiting FAAH leads to significant antinociceptive effects in animal models of AP, supporting the hypothesis
that FAAH plays a crucial role in modulating AP pain through the degradation of anandamide and PEA. This
research project is structured around three specific aims: First, to identify the receptor systems, including
CB1 cannabinoid receptors, PPARα, and others, that mediate the analgesic effects of FAAH inhibition in AP.
Second, to assess changes in FAAH expression and activity, alongside levels of anandamide and PEA,
providing insight into the regulatory mechanisms at play during AP. A subsequent aim will delve into the
cellular substrates mediating analgesia from FAAH inhibition, employing state-of-the-art techniques such as
snRNAseq and CyTOF to profile cell populations and their transcriptional landscapes. The final aim
addresses whether anandamide and PEA exert redundant or synergistic analgesic effects in AP. By revealing
the intricate mechanisms of FAAH-regulated signaling and its impact on pain relief, this project stands to
significantly advance our understanding of non-opioid analgesic pathways in AP. Success in these aims could
lay the groundwork for the development of novel, effective, and safer pain management strategies for AP,
reducing opioid reliance and its associated risks.

Public health relevance
PROJECT NARRATIVE The proposed work addresses the pressing need for effective, non-opioid analgesic strategies for acute pancreatitis (AP), a condition marked by severe abdominal pain and substantial healthcare burden. It aims to explore the therapeutic potential of inhibiting fatty acid amide hydrolase (FAAH) to enhance the analgesic effects of endogenous lipid-signaling molecules, anandamide, and palmitoylethanolamide (PEA), which are currently limited by rapid enzymatic degradation. By identifying the receptor systems involved in FAAH- regulated antinociceptive signaling, elucidating the mechanisms underlying anandamide and PEA's signaling, and pinpointing the cellular substrates for these effects, this project seeks to establish a foundational understanding that could lead to the development of novel analgesic therapies for AP, aligning with the National Institute of Diabetes and Digestive and Kidney Diseases (NIDDK)'s research priorities.